National Health and Nutrition Examination Survey, DXA Osteoporosis Assessment/Study.

To provide support to the National Center for Health Statistics (NCHS), for the DXA Osteoporosis Assessment/Study in/for the National Health and Nutrition Examination Survey (NHANES).